Improving Community Ambulation for Stroke Survivors using Powered Hip Exoskeletons with Adaptive Environmental Controllers

Project Summary Abstract The increased metabolic and biomechanical demands of ambulation limit community mobility in persons with lower limb disability due to neurological damage. There is a critical need for improving the locomotion capabilities of individuals who have walking impairments due to disease to increase their community mobility, independence, and health. Robotic exoskeletons have the potential to assist these individuals by increasing community mobility to improve quality of life. While these devices have incredible potential, current technology does not support dynamic movements common with locomotion such as transitioning between different gaits and supporting a wide variety of walking speeds. One significant challenge in achieving community ambulation with exoskeletons is providing an adaptive control system to accomplish a wide variety of locomotor tasks. Many exoskeletons today are developed without a detailed understanding of the effect of the device on the human musculoskeletal system. This research is interested in studying the question of how the control system affects human biomechanics including kinematic, kinetics and muscle activation patterns. By optimizing exoskeleton controllers based on human biomechanics and adapting control based on task, the biggest benefit to patient populations will be achieved to help advance the state-of-the-art with assistive hip exoskeletons. The long-term research goal is to create powered assistive exoskeletons devices that are of great value to individuals with serious lower limb disabilities by improving clinical outcomes such as walking speed and community ambulation ability. The overall objective of the proposed project is to study the biomechanical effects of using a hip exoskeleton with adaptive controllers for assisting stroke survivors with lower limb deficits to improve their community ambulation capabilities. The central hypothesis overarching both aims is that exoskeleton control that adapts to environmental terrain will improve mobility metrics for human exoskeleton users on community ambulation tasks. The rationale is that since human biomechanics change based on task, exoskeleton controllers likewise need to optimize their assistance levels to match what the human is doing. The first aim of the research is to determine the benefit of adaptive control that changes based on environmental conditions for improving community ambulation capability. The second aim will extend this control architecture to stroke survivors with mobility impairment to provide adaptive assistance during community ambulation conditions and quantify biomechanical and clinical improvements in gait. These aims will have a positive impact by helping to inform the control and design of future powered exoskeletons for assisting individuals with lower limb disabilities.

Public health relevance
Relevance to Public Health This research aims to help individuals with walking disability due to various musculoskeletal disorders with a focus on stroke survivors by improving powered exoskeleton devices. We aim to improve the way a robotic exoskeleton assistive device responds to human users by adapting to user needs and environmental conditions. The results may lead to improved clinical and health comes of stroke survivors by improving community ambulation capability.